Deep sampling of cognitive effects in the human visual system

PROJECT SUMMARY
Much progress has been achieved in building computational models that describe how visual stimuli are encoded
and transformed across the hierarchy of visual areas in the primate brain. However, relatively little attention has
been given to the active component of visual processing, whereby the observer’s engagement in a cognitive or
perceptual task can exert substantial influence on stimulus-evoked activity. The long-term goal of the proposed
research is to develop models that account for not only stimulus-driven but also task-driven effects in the visual
system. To achieve this goal, we invest effort in improving analysis methodology and in generating large high-
quality experimental datasets. In Aim 1, we develop and optimize methods that provide robust fMRI
measurements at the level of single trials. This includes a method that exploits temporal dynamics to isolate
BOLD signals that are more closely related to local neural activity, and an algorithm that improves signal-to-
noise ratio in general linear modeling of fMRI data. In Aim 2, we acquire and prepare a high-field (7T) fMRI
dataset in which a large variety of tasks are performed on a common set of visual stimuli. This dataset exploits
deep sampling of a small number of subjects, and will generate a rich, reusable resource for the fields of cognitive
and computational neuroscience. In Aim 3, we exploit the dataset to test an extant model of how top-down
influences from the intraparietal sulcus modulate responses in ventral visual cortex and to assess how top-down
signals from frontal cortex modulate the fidelity of working memory stimulus encoding in visual cortex. Overall,
this multidisciplinary proposal will deliver reusable methods and data resources, and will push computational
modeling from the domain of stimulus representation into better understanding how the visual system mediates
real-world visual perception and task engagement. Advancing our understanding of the computational
mechanisms underlying visual processing in healthy individuals is a critical step for unraveling the nature of
sensory disorders such as prosopagnosia and dyslexia.

Public health relevance
PROJECT NARRATIVE While the nature of stimulus representation in visual cortex has been heavily studied, relatively little attention has been given to the impact of active task engagement on stimulus-driven visual responses. Using a multidisciplinary approach combining cutting-edge methodological development, extensive high-field (7T) fMRI measurements, theory-driven experimental design, and computational modeling, this project aims to develop formal models characterizing how engagement in different perceptual and cognitive tasks modulates visually- driven responses. Completion of this work will yield reusable methods, data resources, and models of visual information processing. Progress in identifying the computational mechanisms underlying visual perception in healthy individuals is a critical step for understanding the nature of sensory disorders such as prosopagnosia and dyslexia.